INVITED LECTURES AT UNIVERSITIES & CONFERENCES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Resource Staff members are frequently invited to present talks at Universities and conferences in the United States and abroad. Below is a list of such lectures during this reporting period.